Otud1-mediated Prevention of Sarcopenic Obesity during Resistance Exercise Training on High-Fat Diet

Project Summary Anabolic resistance in sarcopenic obesity is a growing concern in the aging population. Increased risk for insulin resistance, type II diabetes, and cardiovascular disease are present in sarcopenic obesity. Developing therapies to combat sarcopenic obesity is of interest to researchers and healthcare professionals. Resistance exercise is one method that is effective in promoting improved glucose uptake and combating diabetes. The mechanistic pathways of resistance exercise are not completely understood and require further dissection under careful controlled conditions. I will use mouse models with these weightlifting cages to promote improvements in skeletal muscle metabolic function. Eight weeks of weight training has proven to be effective in improving body composition and glucose uptake in mice fed high-fat diet. I will also use aged mice on HFD to examine the effects of resistance training in combating sarcopenic obesity. I will also use a genetic approach to examine the proteins that may govern metabolic function. This study will determine how resistance exercise improves glucose uptake under metabolic stress. These finding may help to develop exercise guideline and potential drug targets for better treatments in diabetes.

Public health relevance
PROJECT NARRATIVE Sarcopenic obesity is a widespread problem in the aging population and therapeutic interventions are needed to combat this disease with exercise being one of the best treatment options. Therefore, mechanistic understanding of exercise is required to develop more effective therapies so those not able to exercise can have alternative treatment options. This research will examine resistance exercise-mediated improvements in metabolic function of the skeletal muscle.